Impact of systemic and cerebral acidosis on ischemic stroke and spreading depolarization

PROJECT SUMMARY / ABSTRACT
I am an MD/PhD-trained neurointensivist and physiologist navigating a critical career development transition
towards becoming an independent investigator. My long-term goal is to improve clinical outcomes of patients
with severe ischemic strokes admitted to the intensive care unit (ICU). In the ICU, we can change the levels of
carbon dioxide (CO2) or hydrogen ion (H+) in the bloodstream of intubated, mechanically ventilated patients.
However, we do not know the optimal ranges of H+ or CO2 to target to support brain recovery and limit secondary
injury following stroke. Experimentally elevating systemic CO2 and H+ can reduce the size of strokes in rodents,
by mechanisms that are incompletely understood. H+ and CO2 influence cerebral blood flow, and may also shift
cellular energy phenotypes in neurons or other brain cells. In parallel, H+ and CO2 levels may also inhibit
spreading depolarizations (SDs), waves of powerful neuronal activation that propagate through the vulnerable
brain territories adjacent to infarcts, exert immense energetic stress on neurons, and kill neurons with insufficient
metabolic supply. SDs play a key role in expanding the size of strokes for many days, corresponding to the time
period when patients are in the ICU. In this project, my objective is to identify protective and harmful mechanisms
of acid-base physiology relevant to stroke. My hypothesis is that augmenting H+ will improve metabolic supply
and energy utilization, inhibit SDs, and reduce the size of strokes. I will test this hypothesis with two specific
aims: 1) comparing the effects of systemic and cerebral H+ vs CO2 on cerebral blood flow, cellular energy
metabolism, and stroke outcomes in mice, and 2) testing whether elevated extracellular H+ decreases the
incidence of SD by inhibiting NMDA receptors. The significance of the proposed research is that completing
these studies will provide high-quality physiologic evidence to inform clinical guidelines for the management of
acid-base status in ICU patients with stroke and other acute brain injuries.

Public health relevance
PROJECT NARRATIVE Stroke affects more than 300,000 individuals in the United States annually, and many patients with severe strokes are managed in the intensive care unit on ventilators, allowing physicians to regulate the levels of carbon dioxide and hydrogen ions in the blood stream. However, there is little information about how carbon dioxide and hydrogen ions interact with the brain during stroke, and current treatment guidelines provide no recommendations for optimal levels of carbon dioxide and hydrogen ion in stroke patients. The proposed research will investigate whether hydrogen ions reduce the size of strokes by modifying cellular energy metabolism, inhibiting ion channels called NMDA receptors and reducing waves of damaging neuronal activation called spreading depolarizations.